Enhancement of Effector CD8 Cell Motility through Mitochondrial Metabolism

PROJECT SUMMARY:
CD8 cells play a critical role in the immune response to infections as well as in prevention and restriction of
cancer growth. Cytotoxicity and cytokine production have been identified as the primary mechanisms by which
CD8 cells mediate their immune functions. Furthermore, chemokine-directed migration of CD8 cells is critical for
their localization to lymphoid tissue for immune priming and to sites of infection and inflammation. However, after
CD8 cells traffic to their target tissues, basal cell motility of effector CD8 cells within the tissue is an aspect of
immunity that is poorly understood. Basal cell motility, defined as random walk and exploratory spread, is
essential for effector CD8 cells to locate and engage their cell targets within inflamed tissue, such as a tumor.
Little is known about the factors which could impact motility characteristics (distance, trajectory, speed) of CD8
cells. Mitochondria have been shown to play a critical role in cell motility through mitochondrial ATP and
mitochondrial Ca2+. Mitochondrial Ca2+ enables cell motility through decreasing actin cytoskeleton stiffness. My
recent studies show that IL-21 enhances motility of effector CD8 cells in the absence of TCR signals. I show that
upon activation, effector CD8 cells expanded with IL-2 proliferate and survive but lose their cell polarity, adopting
a round morphology and minimal motility capacity. In contrast, effector CD8 cells expanded with IL-2 plus IL-21
are highly motile. In addition, effector CD8 cells expanded with IL-2 plus IL-21 exhibit increased mitochondrial
membrane potential, mitochondrial ATP, mitochondrial Ca2+, and in vitro cancer cell killing, compared to those
expanded with IL-2 alone. In T cells IL-21 primarily signals through STAT3, and STAT3 has been shown to
translocate to mitochondria and enhance mitochondrial respiration. My data also shows elevated mitochondrial
STAT3 levels in CD8 cells expanded in the presence of IL-2 plus IL-21 compared to those expanded with IL-2
alone. Therefore, I propose that during the expansion of effector CD8 cells, IL-21 enhances CD8 cell motility
by increasing mitochondrial ATP and/or mitochondrial Ca2+ through mitochondrial STAT3, leading to
improved motility within solid tumors, which contributes to a more robust anti-tumor response. To
address this hypothesis, I will: 1) Determine whether IL-21 induces effector CD8 cell motility by increasing
mitochondrial ATP and/or mitochondrial Ca2+ through mitochondrial STAT3 (Aim 1) and 2) Examine whether
effector CD8 cells expanded with IL-2 plus IL-21 exhibit increased motility within solid tumors and enhanced anti-
tumor effects (Aim 2). This study will provide insight into improving effector CD8 cell motility through the IL-21-
mitochondrial STAT3 signaling axis, which can be leveraged in modifying motility of these cells for improving
adoptive T cell cancer therapies and/or reducing progression of CD8 cell-mediated autoimmune diseases, such
as Type I Diabetes.

Public health relevance
PROJECT NARRATIVE: Effective CD8 cell-mediated anti-tumor response depends on the ability of effector CD8 cells to randomly move in search for their cell targets to kill. In this proposal, I will investigate the novel hypothesis that IL-21 enhances effector CD8 cell motility by increasing mitochondrial ATP and/or mitochondrial Ca2+ through activation of mitochondrial STAT3. Results from these studies may lead to the design of novel approaches to enhance the anti-tumor efficacy of adoptive T cell therapies.